Improving Rural Neonatal Birth Outcomes through Neonatal Resuscitation Simulation Training

A rapid and skillful neonatal resuscitation, performed by a confident and knowledgeable medical team, is
crucial to reducing neonatal morbidity and mortality. Maine is the most rural state in the United States and two-
thirds of hospitals have low birth rates of less than one newborn per day. This low birth rate precludes clinical
teams from having regular opportunities to maintain essential neonatal resuscitation skills. Strategies to
improve and maintain neonatal resuscitation skills at rural hospitals are urgently needed and essential to
preserve maternal and infant care at critical access hospitals. In situ simulation training has been shown to be
an effective training tool, allowing delivery room teams to deliberately practice resuscitation skills on a
mannequin in their native clinical setting with experts present to provide guidance and lead a team debriefing
following the training session. This training allows rural clinicians to practice essential resuscitation skills
including adherence to the Neonatal Resuscitation Program (NRP) guidelines, teamwork and communication
through scenarios created to intentionally replicate critical clinical situations. Clinicians then receive directed
feedback in debriefing sessions following the simulation training to review their performance and assess for
areas of improvement.
Though effective, in situ simulation training in rural hospitals is dependent upon the availability of experts and
is cost prohibitive due to the expensive simulation equipment. Telesimulation is an alternative method of
providing simulation training and employs many of the principles of in situ simulation training, with remote
participation from experts for observation and debrief support. In a pilot study, we demonstrated that regular
monthly telesimulation training for 12 months at one rural hospital led to substantial improvements in
adherence to NRP, teamwork and communication scores. In the proposed randomized non-inferiority cluster
trial, we will compare two types of telesimulation technology and employ implementation science to ensure
consistency in the approach across different institutions as well as develop a framework to enable
implementation at other sites. Specifically, we will test an innovative mixed reality hologram (HoloBabyTM) that
our research group has developed and patented against the current high-fidelity standard mannequin
telesimulation used in our pilot study. The primary outcome is the performance of the medical teams during a
resuscitation as measured by a score evaluating adherence to the gold standard NRP guideline.
Communication and teamwork will also be assessed as secondary outcomes and using The Mayo High
Performance Teamwork Scale. The HoloBabyTM leverages novel technology to provide a less expensive
alternative to make simulation training more widely accessible to rural community hospitals allowing rural
clinicians to deliberately practice resuscitation skills, prioritizing learning and competence, without
compromising patient safety.

Public health relevance
Project Narrative Newborns delivered in rural hospitals with low birth rates experience significant disparities including rates of death and brain injury when adverse birthing events necessitate immediate resuscitation because rural delivery teams lack opportunities to practice, leading to poor adherence with Neonatal Resuscitation Program (NRP) guidelines. Simulation training is an evidence based strategy for rural teams to deliberately practice neonatal resuscitation, a high acuity, low frequency occurrence. We will develop and compare the efficacy of a novel, inexpensive hologram-based (HoloBabyTM) telesimulation technology with high-fidelity telesimulation using a randomized non-inferiority cluster trial, assessing NRP adherence, teamwork and communication skills to enable rural delivery room teams to maintain NRP skills and decrease rural neonatal health disparities.